Resolving Occupational Exposure-Induced Lung Disease

Occupational lung diseases are the primary cause of occupation-associated illness in the U.S. based on
frequency, severity, and preventability of the illnesses. Most occupational lung diseases are caused by repeated,
long-term exposure to hazardous agents, but even a severe single exposure can damage the lungs. There are
currently no medical therapies available to ameliorate lung injury/inflammation without exerting untoward side
effects. The inability to adequately treat workers following occupational inflammatory exposure leads to chronic
disease, and workers with respiratory disease have a higher incidence of filing for disability compared to those
without respiratory disease. Importantly, there is a re-emergence in traditional respiratory occupational hazards
caused by bacteria biological agents such as endotoxin. Exposures to endotoxin are high in agricultural
production and emerging sectors such as waste treatment, recycling, biotech food production and processing
industries. The COVID19 pandemic rapidly transpired as a devastating occupational respiratory viral-induced
health illness significantly impacting workers of food processing plants with limited efficacious therapies. Without
guidelines or therapies for the management of occupational exposure-induced lung injury/inflammation, there is
an urgent and unmet need to identify alternative approaches to reduce disease burden. Our long-term goal is to
find new strategies to promote the resolution of occupational exposure-associated lung inflammatory disease
before it progresses to irreversible lung disease. Our recent discoveries using single cell RNA sequencing
coupled with flow cytometry strongly implicate the recruited monocyte/macrophage, and we uncovered that
delivering amphiregulin and interleukin (IL)-10 as lung-directed therapies appear to beneficially effect lung
recovery processes post-occupational exposures. Our central hypothesis is that targeted cellular and mediator
interventional approaches following various occupational inflammatory inhalant exposures can be developed to
hasten lung recovery to reduce disease development. To model occupational bacterial and viral component-
induced lung inflammation, Toll-like receptor (TLR) agonists and agriculture organic dust extract will be utilized.
We seek to test our hypothesis by addressing three independent and synergistic aims. In Aim 1, we will determine
the time-dependent cellular and specific monocyte/macrophage lung cell events following occupational
exposures and whether targeting these cells hastens lung recovery. In Aim 2, we will determine the role of
amphiregulin as a potential lung-directed therapeutic approach in the resolution inhalant occupational exposures.
In Aim 3, we will determine how inhalant IL-10 treatment works to promote repair in the recovery process after
lung inflammation induced by occupational exposures. The results of these studies will have an important
positive impact because they lay the pre-clinical groundwork for understanding key cellular and mediator
responses, and the ultimate development of new strategies to treat occupational exposure-induced lung
inflammation prior to the development of irreversible lung disease.

Public health relevance
This project will identify biologic mechanisms underpinning the temporal continuum in the lung following occupational bio-aerosol bacterial and viral component exposure-induced lung inflammation that will potentially lead to novel therapeutic lung-directed strategies aimed at hastening resolution of lung inflammatory disease processes following exposure to occupational inhalant biohazards.